Optimizing and understanding semantic feature analysis treatment for aphasia: A randomized controlled comparative-effectiveness trial

The parent study for this administrative supplement is a randomized comparative effectiveness trial that
examines whether active manipulation of a key component of semantic feature analysis (SFA) treatment for
word-finding difficulty in aphasia improves outcomes. The component in question is the number of semantic
features that persons with aphasia are asked to generate on each treatment trial. Study participants (n=40) will
be recruited and randomized to receive either a many-features version of SFA or a few-features version. In the
many-features condition, participants will be asked to generate 11 semantic features for each word practiced.
Participants assigned to the few-features condition will be asked to generate 5 features for each word
practiced. The total treatment time will be equated in the two conditions. Because each trial will take less time
in the few-features condition, participants in this group will cycle through the lists of treated items more often,
providing them with more opportunities to practice the phonological form of the targets, at the expense of more
elaborated feature generation practice. Correspondingly, the many-features group will receive more practice
generating semantic features, at the expense of having fewer opportunities to practice the target word forms.
Study participants will be housed locally at the Pittsburgh site for five weeks during which they will receive
60 hours of SFA treatment. At two timepoints before beginning treatment, at treatment exit, and at 1-month
follow-up, their ability to name pictures of treated and untreated, semantically related nouns will be assessed.
Other secondary outcomes, including measures of connected speech and patient-reported communication
ability will also be collected on the same schedule. In order to address unresolved questions about the
underlying cognitive and neural mechanisms of SFA, a subset of participants will also receive concurrent pre-
and post-treatment assessment of automatic word processing ability using eye-tracking methods and
functional magnetic resonance imaging (fMRI).
The language testing results will be used to determine the appropriate balance of feature generation
practice vs. word form practice to optimize SFA outcomes. The eye-tracking results will be used to infer
whether SFA’s positive effects can be attributed to improved activation of lexical-semantic representations,
improved ability to inhibit competing representations, or both. The fMRI results will be used to identify the brain
networks and activation changes associated with changes in naming ability resulting from SFA. This study will
provide theoretically and clinically relevant information about how aphasia treatment should be delivered and
the neurocognitive mechanisms underlying its effects. The aim of this administrative supplement project is to
examine whether task-based brain activation patterns associated with language performance are stable across
the two pre-treatment scanning sessions i to condition the interpretation of changes observed following
treatment.

Public health relevance
The parent study for this administrative supplement is a randomized controlled comparative effectiveness trial that examines manipulation of a key component of an established and efficacious treatment for naming impairments in aphasia, along with cognitive and brain correlates of treatment success. Study participants’ performance on standardized and study-specific measures will be used to determine which version of the treatment provides superior outcomes, and measures of automatic language processing and functional brain imaging will also be used to identify the underlying neurocognitive mechanisms associated with positive treatment response. The goal of this supplement is support the development of a potential healthcare researcher by providing experience and mentorship in the context of an examination of the stability of task- related functioning brain activation patterns across two pre-treatment baseline imaging sessions.